Cancer Research Career Enhancement and Related Activities

PROJECT SUMMARY/ABSTRACT (CANCER RESEARCH CAREER ENHANCEMENT & RELATED
ACTIVITIES)
The UMCCC is dedicated to training and developing the next generation of cancer researchers. The University
of Michigan Comprehensive Cancer Center (UMCCC) demonstrates this commitment through strong financial
support (>$300,000 annually), robust structures and processes, and the dedicated efforts of its members. An
exemplary track record of established, NCI-funded research training programs extends for 30 years, and
graduates from UMCCC-affiliated training programs – from basic research to population sciences – serve as
leaders in major academic centers across the country. Thus, through its educational and career enhancement
initiatives, the UMCCC has had a sustained and prominent impact on cancer research and its workforce
nationally and internationally. U-M is also home to a diverse and robust collection of pre- and post-doctoral
medical education programs. There are over 100 ACGME-accredited post-graduate programs at U-M and
UMCCC members have key teaching and administrative roles in Medical Hematology/Oncology, Pediatric
Hematology/Oncology, Radiation Oncology, Surgical Oncology, Urologic Oncology, Dermatologic Oncology,
Gynecologic Oncology, and Pathology training programs. These programs together graduate over 25 cancer
specialists annually.